Clonal Hematopoeisis of Indeterminate Potential and Risk of Autopsy-defined Sudden Cardiac Death

PROJECT SUMMARY/ABSTRACT
Clonal hematopoiesis of indeterminate potential (CHIP) is the expansion of leukocytes derived from a
clone with pre-leukemic potential that does not fulfill diagnostic criteria for a hematologic malignancy. Recent
large-scale studies have demonstrated an association between mutations in CHIP genes, mostly in TET2,
DNMT3A, ASXL1, and a 30-40% increased risk of non-cancer mortality, a 2-fold increased risk of ischemic
stroke and coronary artery disease (CAD), and a cumulative increase in cardiovascular (CV) death in the
general population. Mechanistic models propose a phenotypic switch in immune cells, chiefly macrophages,
with CHIP mutations leading to increased vascular inflammation and accelerated CAD. Despite these
data suggesting that CHIP is significantly associated with increased CV events and overall mortality, it is
unknown whether CHIP is associated with sudden cardiac death (SCD), the most feared manifestation of CVD.
Our NHLBI-funded ongoing POST SCD Study, which has autopsied 97% of >1000 consecutive SCDs since
2011, is the first and only prospective unselected adult SCD cohort to use autopsy to refine the SCD
phenotype to true cardiac and arrhythmic causes. We recently reported that nearly half of conventionally-
defined presumed SCDs were in fact non-cardiac. Importantly, the large-scale exome sequencing studies that
initially defined the carrier rates and risk of a cardiovascular event relied on presumed causes of death and
often assessed for the presence of CHIP years prior to death.
Our central hypothesis is that CHIP-mutant resident macrophages increase the risk of fatal
arrhythmias across all underlying substrates of SCD found in POST SCD (CAD, hypertrophy, CM) by
increasing interstitial myocardial fibrosis and decreasing electrical coupling. We will test this hypothesis by: (1)
determining the population carrier rate of CHIP at the time of SCD and its associated independent risk, (2)
establish that CHIP increases the infiltration of macrophages and interstitial fibrosis within the cardiac
interstitium, including the conduction system, and (3) define the transcriptional mechanism by which CHIP
macrophages increase vulnerable myocardial substrate for SCD. We anticipate that this innovative approach
will yield the following outcomes: (1) inform potential clinical use of CHIP for SCD risk stratification; (2)
establish the role of macrophages on myocardium and conduction system beyond the vascular compartment
and its correlation with fibrotic arrhythmogenic substrate common to all sub-phenotypes of SCD, and the
modulating effect of CHIP on this process; (3) determine the RNA profiles of CHIP-mutant resident
macrophages vs. wildtype macrophages to reveal insights into CHIP-specific effects on the cellular milieu of
hearts vulnerable to SCD to thus potentially identify new biologic targets for diagnosis and/or therapeutics.
Thus, the proposed research will fundamentally advance our knowledge of how CHIP increases CV mortality,
specifically SCD, and potentially identify a new risk factor for SCD.

Public health relevance
PROJECT NARRATIVE Clonal hematopoiesis of indeterminate potential (CHIP) is an occult pre-cancerous proliferation of cells in the blood that leads to an increase in cardiovascular disease and overall mortality. The association between CHIP and sudden cardiac death (SCD) and the mechanism by which CHIP might contribute to SCD remain unknown. We propose targeted sequencing for CHIP in blood and heart samples from our unique cohort of autopsy-confirmed SCDs, and quantitative histologic and molecular phenotyping of heart tissue to determine how CHIP contributes to vulnerable substrate for lethal arrhythmias underlying SCD.